Administrative Core

Oversight and communications of the Project will be coordinated by the Principal Investigator, Robert Tjian, and through the principal scientific leaders, an Executive Committee, a Scientific Advisory Board, and a Management Committee. The Program's organizational structure will ensure effective communications, management, and oversight, and is designed to promote a creative and flexible structure to help the Program's researchers practice the best possible science. The Program's progress will be evaluated regularly, and at several levels. The Science Advisory Board will perform an Annual Review, the Executive Committee will meet biannually to review progress, and the Management Committee will meet monthly to provide updates, identify operational issues, and coordinate cross-cutting issues. Communications systems and processes will include a public and internal web site, a desktop videoconferencing system, and an Annual Report to share news about all aspects of the Program. The Program will be administered under the umbrella of the California Institute for Quantitative Biomedical Research (QB3), which provides administrative infrastructure for large-scale interdependent science programs funded by a variety of federal, state, and private agencies. The QB3 Deputy Director, Diane Leite, will provide managerial oversight to the Program's administrative infrastructure. In addition to its dedicated administrative coordinator, the Program will have access to the QB3 business support structure, including a human resources specialist and a large-scale grants management office.